Neuroinflammation-induced lymphangiogenesis in the CNS

PROJECT SUMMARY/ABSTRACT
Adaptive immunity in most tissues of the body involves the drainage of antigens or antigen presenting cells within
conventional lymphatic vessels to the draining lymph nodes where antigen is presented to T cells. However,
there are no conventional lymphatic vessels within the CNS parenchyma. Alternatively, it has been hypothesized
that antigens, antigen presenting cells, and CSF may drain from the CNS into lymphatics near the cribriform
plate or dura to maintain fluid homeostasis and antigen drainage during steady-state conditions, yet little is known
about the role of these lymphatic vessels during neuroinflammation.
We discovered that lymphatic vessels near the cribriform plate undergo extensive in situ neo-lymphangiogenesis
during experimental autoimmune encephalomyelitis (EAE), a mouse model of Multiple Sclerosis. Our preliminary
data show that these neo-lymphatic vessels near the cribriform plate are functionally able to drain both CSF and
cells that were once in the CNS parenchyma. We further found the during EAE, VEGFC protein is produced by
infiltrating macrophages and dendritic cells to promote VEGFR3 dependent neo-lymphangiogenesis near the
cribriform plate. These data are the first to describe neo-lymphangiogenesis near the cribriform plate during
neuroinflammation. The long-term objective of this project is to characterize the functionality and contribution
of newly formed lymphoid vessels near to the cribriform plate to autoimmunity and stroke of the CNS.
The specific objectives of this proposal are (1) to define the characteristics and regulatory mechanisms driving
neo-lymphangiogenesis near the cribriform plate (Aim 1); (2) to test the functionality of neo-lymphatic vessels
near the cribriform plate and compare them to different CNS area lymphatics (Aim 2); and (3) to understand the
translational value of exacerbating or inhibiting neo-lymphangiogenesis near the cribriform plate in order to treat
CNS diseases (Aim 3).
Pharmacological inhibition or exacerbation of neo-lymphangiogensis to modulate pathology in CNS diseases
may have potential therapeutic values for CNS autoimmunity and ischemic trauma.

Public health relevance
PROJECT NARRATIVE Understanding the role of lymphatic vessels in the drainage of CSF, antigens, and immune cells from the CNS is critical for understanding biological mechanisms and discovering potential clinical targets. Dysfunction of CNS drainage of antigens and immune cells through CNS lymphatics is speculated to be involved in several neuroinflammatory disorders such as Multiple Sclerosis, Alzheimer's disease, and lymphoedema. We show evidence of in situ neo-lymphangiogenesis near the cribriform plate during neuroinflammation, which may have functional consequences for the drainage of CSF, antigens, and immune cells. Our data suggests that neuroinflammation may recruit monocytes to help facilitate the drainage of antigens and fluid from the CNS by inducing neo-lymphangiogenesis. These data implicate neo-lymphangiogenesis as a contributing factor to CNS neuroinflammation, and pharmacological manipulation of neo-lymphangiogenesis may be a potential clinical target for CNS inflammatory diseases.